Building a shared decision making implementation strategy for the emerging paradigm of precision cancer screening

PROJECT SUMMARY
Background: Prostate cancer screening with prostate-specific antigen (PSA) testing only modestly reduces
the number of deaths at the expense of increasing the morbidity associated with overdiagnosed cases and
unnecessary treatment. As a result, clinical guidelines recommend against universal PSA screening for men
but do call for shared decision making (SDM). SDM involves discussing the benefits and harms of interventions
and incorporating patient preferences into decisions. Effective SDM requires healthcare systems-level support,
promotion of SDM skills for practitioners and patients, as well as context-specific knowledge for all involved.
Without proper planning for and support for providers to implement SDM and patients to participate, such
guideline-recommended discussions cannot be expected. Meanwhile, the next frontier in cancer screening is a
new paradigm of precision screening, in which an individual’s genetic make-up may be used to stratify their
level of future cancer risk and inform whether, how early, and how often they should be screened. Polygenic
risk scores (PRS) are composite risk estimates derived from large, population-based genome-wide association
studies. The goal of incorporating PRS into population screening is to reduce the harms of overdiagnosis and
unnecessary treatment for low-risk individuals while preserving screening benefits for those at highest risk.
Significance: Both precision screening and SDM are major pillars of the new White House Cancer Moonshot
v2.0. PRS-informed prostate cancer screening is likely to be the first of these precision screenings within the
Veterans’ Health Administration (VHA). Our project is also clearly aligned with VHA’s patient-centered learning
initiative to turn VHA into a health literate care organization.
Innovation and Impact: This clinical innovation will have direct impact on primary care, where cancer
screening decisions are made. The limited genetic counseling workforce is not sufficient to offload all
conversations about PRS from patient-aligned care teams (PACTs) in which primary care providers (PCPs)
work. The potential effect of PRS-guided screening on equity is also a concern. Current guidelines consider
Black race risk factor that might favor PSA screening, as Black men are twice as likely to die of prostate cancer
than white men. Any new screening paradigm must consider existing disparities and a historical context of
racial discrimination and mistrust for a prostate cancer PRS is to be accepted among racially diverse patients.
Specific Aims: To proactively address VHA’s needs in implementing a prostate cancer PRS using SDM into
primary care, we propose the following aims: 1) Qualitatively describe Veterans’ decision support needs to
discuss PRS and use them in SDM about prostate cancer screening; 2) Qualitatively describe and
quantitatively determine the perceived competency, perceived barriers, and informational and support needs
for implementing SDM around precision prostate cancer screening among VHA PACT members nationally;
and, 3) Engage with our operational partners and stakeholders in Intervention Mapping for the development of
a multifaceted intervention, implementation plan, and evaluation plan to support PACT members and Veterans
to engage in high-quality SDM around precision cancer screening.
Methodology: Aim 1 and 2 will include qualitative interviews with Veterans (Aim 1; n=40) and PACT member
interviews (Aim 2; n=45). Aim 2 also includes a national survey of PACT PCPs and nurses. Aim 3 consists of
Intervention Mapping: a process that engages stakeholders and results in intervention development and
implementation and evaluation plans. This third aim is not human subjects research.
Next Steps/Implementation: By the end of this project period, our operational partners will be prepared to
refine all intervention components and have feasible, stakeholder-informed implementation and evaluation
plans to incorporate SDM and PRS into real-world prostate cancer screening discussions with patients.

Public health relevance
PROJECT NARRATIVE Because of the harms/benefit ratio for prostate cancer screening, clinical guidelines generally recommend against universal PSA screening for men but do call for shared decision making (SDM). SDM involves discussing the benefits and harms of medical interventions and incorporating patient preferences into decisions. The next frontier in cancer screening is a new paradigm of precision screening, in which an individual’s genetic make-up may be used to stratify their level of future cancer risk and inform whether, how early, and how often they should be screened. Both precision screening and SDM are part of the Cancer Moonshot v2.0. This also has implications for SDM, as Veterans and providers will need to integrate this new type of information into decisions. We propose to identify the most effective ways by which primary care in VHA can make shared decision making a routine part of their usual care.